Pathology Core

PI's Supported by the Pathology Core[unreadable] [unreadable] Requester Lab/Brch[unreadable] [unreadable] Cameron Dezfulian VMB[unreadable] Ceciia Lo LDB[unreadable] Gustavo Paheco PCCMB[unreadable] Ju-Gyeong Kang VMB[unreadable] Julie, Heroux CC[unreadable] Karin Fredrickson PCCMB[unreadable] Katherine Wood VMB[unreadable] Q. Yu/Yu LDB[unreadable] Qais Ali VMB[unreadable] Xianglan Yao VMB[unreadable] Xufeng Wu LCB[unreadable] Y. Zhou Surgery[unreadable] J, Kato PCCMB[unreadable] D. Orlic CVM[unreadable] H. Katagiri EO[unreadable] S. Cecchini CC[unreadable] T. McCann EO[unreadable] R. Spolski LMI[unreadable] T. Thach EO[unreadable] S. Kasaoka Path[unreadable] Zhen Zhang LDB[unreadable] Colin Berry TMB[unreadable] Chris Combs LMC[unreadable] Bishwanath Chatterjee LDB[unreadable] Tomoiku Takaku Hematology[unreadable] Robert E. Donahue Hematology[unreadable] Anglique Biancotto Flow cytometry core [unreadable] Connie Glasgow TMB